Metabolism and neuronal viability of the retina

PROJECT SUMMARY
Retinal dystrophy-caused vision impairment severely impacts the quality of life for millions of people world-
wide. Despite advances in recent decades, current medicine still lacks safe and effective treatments for many
blinding diseases. Neuroprotective therapies aimed at delaying neuronal loss and preserving visual function
could, therefore, be a useful strategy for treating slow-progressing blinding diseases such as age-related
macular degeneration and glaucoma. The cytokine ciliary neurotrophic factor (CNTF) is known to act as a
potent neuroprotective agent in a variety of retinal degeneration models. However, chronic exposure to high
doses of CNTF results in the suppression of visual function in spite of preventing neuronal death. In order to
leverage the beneficial while avoiding the detrimental effects of CNTF, it is critical to understand CNTF signal-
induced cellular events in the retina.
To provide greater insight into ongoing CNTF clinical trials aimed at treating blinding diseases, we performed
molecular genetic analyses in mouse retinal degeneration models infected with a viral vector we engineered
to express the same human recombinant CNTF being used in clinical trials. We demonstrated that CNTF
initially targets Muller glia, which in turn activate a signaling loop between Muller glia and photoreceptors,
leading to photoreceptor survival. We also showed that CNTF signaling rapidly and extensively alters the
retinal transcriptome, which may underlie the CNTF-mediated suppression of visual function. In addition, we
have demonstrated that removal of a cytokine signaling inhibitor in rod photoreceptors is sufficient to enhance
their survival in the absence of exogenous CNTF, indicating that modulation of endogenous cytokine signaling
can promote photoreceptor viability. Moreover, our recent study has revealed that CNTF treatment profoundly
impacts retinal metabolism, resulting in enhanced aerobic glycolysis and anabolism, elevated energy
production, and restored retinal redox status.
The proposed research will combine molecular and biochemical approaches to further our understanding on
the cellular process elicited by CNTF in the retina. We will examine cell type-specific transcriptomic changes
and altered metabolic pathways to fully assess effects of CNTF treatments on various cell types. We will
evaluate the role of a key glycolytic enzyme in photoreceptor maintenance and survival. We will also
determine the distinct functions of cytokine signaling components involved in the CNTF-induced metabolic
changes. Outcomes of the proposed research will advance our knowledge of neuroprotection mechanisms,
especially the role of metabolism in sustaining neuronal survival, and thus facilitate the development of more
efficacious treatments for retinal degeneration.

Public health relevance
PROJECT NARRATIVE Vision impairment has devastating effects on human perception and quality of life. The major blinding diseases, such as age-related macular degeneration (AMD) and glaucoma, involve the permanent loss of retinal neurons. The proposed research will study neuroprotection mechanisms using advanced molecular and genetic approaches, and test new therapeutic strategies for retinal degeneration.